Neuromodulation and Robustness of Neurons and Networks

Project Summary/Abstract
This is a request to consolidate three ongoing NINDS-funded proposals that deal
with neuromodulation (R37 NS 17813), temperature compensation (R01 NS 81012), and
computational models of homeostatic regulation of intrinsic excitability (Project #4 of
P01 NS07949). Together these projects comprise a coherent attempt to understand
brain circuit stability in the face of: a) extensive neuromodulation, b) constant and rapid
turnover of ion channels and receptors, and c) degenerate and multiple solutions at the
single neuron and circuit level. These questions arise from years of computational and
experimental work using the small circuits of the crustacean stomatogastric ganglion
(STG), but address general problems relevant to all nervous systems, from invertebrates
to humans. Future experiments will combine experimental and computational work to
understand the correlations in biological parameters in neurons and networks that allow
any given parameter to be variable while the circuit itself retains robustness. Animal to
animal variability in response to perturbations will be measured, the strengths of all of
the synapses in STG circuits will be measured, and the regulation of multiple
neuromodulator receptors by single neurons will be studied. Additionally, self-tuning
models will be developed to find sets of neuronal parameters that allow neurons to
maintain stability in response to perturbations. This work will illuminate the extent to
which the same animal can potentially generate similar behavior by substantially
different (degenerate) circuit mechanisms at different times. If so, this can shed light on
how larger circuits may switch between a number of degenerate circuit mechanisms to
generate stable behaviors over time.

Public health relevance
Project Narrative Neurons must constantly rebuild themselves as the membrane proteins that give rise to synaptic connectivity and electrical excitability are replaced. At the same time, brain circuits must be stable. The goals of this project are to understand how individual animals achieve robust function over time in the face of the need to respond flexibly to environmental perturbations.